BSL-3 Practices Core

Project Summary:
The UAB Southeastern Biocontainment Laboratory (SEBLAB) is supported by personnel with diverse expertise
across the campus including: physical security, police, facilities, information technology, occupational medicine,
animal resources, research scientists, and biosafety experts all of whom require initial and continuous training
to sustain safe and efficient high containment operations. Core-2 seeks to support a solid and effective biosafety
workforce and provide access to specific external training opportunities that tether biosafety concepts and
principles to the specific specialties outlined above. Personnel from selected units will be funded to attend
external training opportunities that complement their high containment roles. Training will entail select
conferences, webinars, courses, and a personnel exchange program with other network regional biocontainment
labs (RBLs), enabling specialists from one institution to observe how their counterparts conduct operations.
Individuals sent for external training will then serve as subject matter experts within their specific units and work
closely with UAB Biosafety to enhance and implement high quality internal training programs critical to the safe
execution of high containment research in the UAB SEBLAB.